High Performance Computing and Machine Learning Infrastructure for Oregon Life Sciences

Project Summary/Abstract
Oregon Health & Science University (OHSU) requests funds for the “High Performance Computing and
Machine Learning Infrastructure for Oregon Life Sciences” to refresh outdated equipment and expand existing
hardware resulting in a 39% net increase in memory and 183% increase in GPUs. Exacloud, the current high-
performance computing (HPC) infrastructure at OHSU and Knight Cancer Institute was first installed in 2014
and expanded in subsequent years. The improvements will meet current demands, support recent NIH-funded
growth in quantitative sciences, leverage the shared expertise of computational researchers at OHSU, and
meet institutional needs at least until 2026. This proposal serves 61 life sciences research groups in the
Portland area, 43 of which are actively funded by NIH and 26 are presented here as Major or Minor users who
are listed as Contact PI on NIH grants totaling more than $33 million in annual funding. The scientific use
cases for this computational platform include cancer, diabetes, infectious disease, genomics, radiomics,
artificial intelligence, and modelling research. Overall, NIH research projects with over $89 million in annual
NIH funding are listed in this proposal which would directly benefit from the improved system.
The current OHSU Exacloud operates a 282-node, 9176-core high-performance computing (HPC) cluster. 36%
of the current hardware is end-of-life, slowing OHSU research. We seek funds to purchase 102 nodes with 768
GB memory each (3264 cores and 176 GPUs). After discontinuing 127 nodes we will leverage the existing
Exacloud infrastructure to create a 257 node/8888 core cluster with 282 GPUs that can accommodate 15%
annual growth in computing and data intensive science for OHSU users as the new CPU cores are 86% faster
than the equipment they will replace. This resource will enable open science, support cross-institutional
collaboration, and manage increased demands on computational resources leveraging shared OHSU / Knight
research needs and OHSU shared services computational expertise.
OHSU and the Knight Cancer Institute and achieve more than $330 million of NIH funding per year. The Knight
Cancer Institute is the only Oregon-based NCI-designated Comprehensive Cancer Center with innovative
research, including Computational Biology and Machine Learning. OHSU performs high-impact global research
as a preeminent research university in Oregon and is 12th among American research universities in generating
new patents. OHSU investigators use innovative tools such as machine learning, genomics, and mathematical
modeling to address important high-impact health concerns including cancer, infectious diseases, diabetes,
and dementia. The improved Exacloud will support this vibrant life science research community and provide a
platform for health-focused innovations.

Public health relevance
Project Narrative (Public Health Relevance) We are requesting funds to refresh and expand the Exacloud, an established high-performance computing (HPC) environment and private cloud collaboration space to address needs resulting from 3 trends: consistent growth of quantitative research in number of research groups and in complexity of computational demands, exploding dataset sizes produced by modern instruments, and the increase of technical debt through end-of-life hardware. Access to fast and reliable computational power is essential for interpreting data from large-scale life sciences studies. The prevention, detection, and treatment of cancer, Alzheimer, diabetes, and other life-threatening diseases are major areas of NIH-funded research that will greatly benefit from the improved performance of the requested HPC cluster expansion.